Applying Positive Deviance Methods to Harness Optimal Practices for Effective Pain Management in Community Living Centers

Background: Unrelieved pain is highly prevalent and devastating for Veterans in VA’s 134 Community Living
Centers (CLCs). Imminent removal of pain as one of the CLC quality measures offers an opportunity, per VA’s
Office of Geriatrics and Extended Care (GEC), to develop new, risk-adjusted measures that more accurately
characterize CLC pain management. These measures can identify CLCs successful at pain management while
minimizing biased underestimates for CLCs with the sickest residents. Then, by diving deeply into structures
and processes of high performers, we can learn how to intervene. My background in gerontology, quantitative
methods, and implementation science partially prepares me for this work. But I need additional training in risk
adjustment, qualitative research, cutting-edge analytic methods, and intervention study designs for the study
and my health services research career to succeed.
Specific Aims: The proposed CDA simultaneously fills the considerable gaps in my background and provides
VA with rigorous, actionable research on which to ground future quality improvement efforts. A social-
ecological model frames the work. GEC commits to serving as an invested partner. I have 3 aims, which I will
achieve with my mentors and training.
1. Evaluate how risk adjustment changes judgements of CLC pain management performance.
2. Use mixed methods to perform in-depth studies of CLCs with high outlying performance.
3. Adapt an existing, evidence-based intervention comprising lessons learned from “positive deviants.”
Methods: Aim 1: Using VA administrative data of CLC residents, I will (1) calculate unadjusted pain measures,
(2) apply risk adjustment, (3) assess the measures’ reliability and validity, and (4) identify high and low outlying
performance on pain management. Aim 2: I will use quantitative (survey) and qualitative data from staff and
residents at 5 top-performing CLCs, contrasted with qualitative data from 5 low-performing CLCs, to develop
hypotheses of contextual factors and pain management practices unique to positive deviants. I will test causal
relationships using configurational comparative analytic methods. Aim 3: I will adapt an existing nursing home
pain management intervention for use in VA CLCs, using empirical evidence from Aim 2 about necessary
conditions for optimal pain management. A modified e-Delphi panel of CLC stakeholders and pain
management experts will provide feedback on the intervention package’s design. I will use a developmental
formative evaluation of qualitative data from staff at 1 low-performing CLC to assess the intervention’s
feasibility and acceptability, in preparation for rigorous testing in future work.
Expected Results and Next Steps: I will provide GEC with interim deliverables to enable assessment of CLC
pain management quality, guide CLC policy, and support clinical practice in CLCs struggling with pain
management. Knowledge from this CDA will lead me to develop studies to refine risk adjustment methods for
quality measurement in other critical areas and to rigorously evaluate, using a hybrid type II design, clinical
effectiveness and implementation of the intervention.
Significance & Relevance to Veterans’ Health: Coming at a critical juncture in my VA research career, this
timely study responds to the VA priority of Greater Choice for Veterans, ORD’s priority to increase substantial
real-world impact of VA research, and HSR&D’s Long-term Care and Opioid/Pain priority domains. Although
pain is highly prevalent and debilitating for the 42,000 vulnerable Veterans CLCs serve, almost nothing is
systematically known about CLCs’ pain management quality. And current pain measures are about to
disappear. This study seizes this opportunity, developing nuanced, VA-specific approaches that are custom-
made to reflect the accurate state of CLC pain management and help improve VA long-term care.

Public health relevance
Unrelieved pain is highly prevalent and devastating for Veterans in Community Living Centers (CLCs). This Career Development Award capitalizes on the imminent removal of pain as one of the CLC quality measures to develop new, risk-adjusted measures that more accurately characterize pain management. These measures will identify top-performing CLCs. By diving deeply into their unique organizational structures and processes for achieving high quality pain management, we can learn how to intervene. My background in gerontology, quantitative methods, and implementation science partially prepares me for this work. The proposed CDA simultaneously fills considerable gaps in my training—in risk adjustment, qualitative research, cutting-edge analytic methods, and intervention study design—and provides VA with rigorous, actionable research on which to ground future quality improvement efforts.